CSVD and AD: the drivers of late life dementia

Grant Summary:
Cerebral small vessel disease (CSVD) is the most prevalent neurological disorder in the
elderly. Broadly, CSVD comprises the gradual remodeling of brain microvessels due to
hypertension, global hypoperfusion or other vascular risk factors. In addition to increasing the
risk of stroke and late life dementia, CSVD accelerates neurodegeneration in sporadic late
onset Alzheimer's Disease (AD). However, the mechanism of the CSVD/AD interaction remains
unclear and restoration of hypertension and other vascular risk factors, in longitudinal
randomized clinical trials, lowers the risk for late-life dementia by only 5-20%. These data
suggest that deleterious pathways initiated in mid-life CSVD are not fully rescued by treatments
presently in clinical practice. Building upon our previous work, we will examine the
spatiotemporal evolution of neuronal and microvascular network changes in CSVD alone and
within an AD susceptible environment, so as to assess the long-term effects of the CSVD-
induced injury. We will map the cognitive consequences of the changes in neurovascular
function and use a multifaceted approach to identify the underlying neurobiological mechanisms
leading to cognitive compromise. As less blood flow reaches the brain microcirculation from
hemodynamic disturbances caused by CSVD, neurons associated with cognitive function will
likely engage in suboptimal neurotransmission, thus negatively affecting cognitive behavior. We
propose that treatment of vascular risk factors and endogenous neurovascular remodeling can
achieve only partial functional recovery of CSVD. In an AD-susceptible environment,
neurovascular remodeling will be further compromised; significant functional deficits persist in
the chronic phase CSVD, and later-life disease is exacerbated. We will pursue the following
objectives:
1. Identify short-term effects of CSVD on neurovascular function and cognition in AD
susceptible environment vs. in healthy brain.
2. Identify long-term effects of CSVD on neurovascular function and cognition with AD
progression vs. in healthy aging.
3. Downregulate ROCK signaling so as to ameliorate neurovascular dysfunction and
stabilize cognitive decline.
To effect significant neurovascular network injury on a slow temporal scale, we will gradually
induce cerebral small vessel disease in non-transgenic and TgAD rats at the early-amyloid
stage. We will bring to bear our expertise to conduct a battery of cognitive tests, in vivo MRI and
two-photon fluorescence microscopy, in vivo electrophysiology, followed by post mortem
pathological analyses. After pharmacological re-establishment of vascular risk factors and
normalization of global brain blood flow, we will examine the brain microvascular network
function, neuronal network function and pathological sequelae. These experiments will pinpoint
the pathways still impaired after cessation of vascular insult, thus identifying potential targets for
development of multi-drug therapeutic strategies. Using this strategy, our preliminary data in
both CSVD alone and within an AD susceptible environment indicate up-regulation of the RhoA
kinase pathway in the vasculature 30-days post-cessation of vascular insult in conjunction with
compromised neurovascular function. Our approach to confirm the role of RhoA signaling and
identify the downstream pathways contributing to late-life dementia will identify interventions to
not only restore vascular function but prevent cognitive decline.

Public health relevance
Cerebral small vessel disease (CSVD), the most common neurological disease of the elderly, contributes to cognitive dysfunction and accelerates neurodegeneration in Alzheimer's Disease (AD). Current treatments to normalize vascular dysfunction in CSVD, such as high blood pressure, lower the risk of late-life dementia by only 5-20%. Therefore, understanding the link between cerebral small vessel disease and AD and developing more effective interventions is important for healthy aging.